A portable photoacoustic imager for diagnosing vascular diseases

Project Summary/Abstract
Vascular diseases are the leading cause of death worldwide. Some common vascular diseases include: cardio
vascular disease, stroke, and peripheral artery disease (PAD). Many of these vascular diseases need point-of-
care (POC) diagnosis and monitoring using non-ionizing, non-invasive and cost-effective approaches. Although
Doppler ultrasound meets all these requirements, it only maps blood flow, which is operator dependent and
influenced by motion artifacts, resulting in limited sensitivity and specificity to detect the disease in its early stage.
A POC technique that provides direct label-free molecular and functional information of vasculature is needed to
reliably detect and monitor vascular diseases.
A mobile photoacoustic imager (mPAI) is proposed for diagnosing various vascular diseases in resource poor
settings of the world. Leveraging on strong multispectral optical absorption of oxy- and de-oxy hemoglobins, the
mPAI is capable of providing multi-parametric information of deep vasculature, such as blood oxygen saturation,
plaque lipids, blood flow and blood clot. The mPAI is non-invasive, real time and uses non-ionizing optical and
ultrasound radiation. This will be the first and perhaps the only portable technology capable of deriving such
multiparametric functional information of deep vasculature without the use of contrast agents. Competing
technologies cannot provide such a direct information of vascular health, and certainly not in a compact portable
device form. Health care providers can use the mPAI to instantly diagnose several vascular diseases affecting
humans of all ages, including infants.
In the R21 phase, Aim1 will design and develop the mPAI, integrating the low-cost optical illumination and
piezoelectric micromachined ultrasound transducer (PMUT) arrays. Dr. Rundra Pratap team from the Indian
Institute of Science (IISc), Bangalore, will design and fabricate the PMUT arrays. Dr. Kothapalli team will develop
the mPAI and validate its performance on tissue mimicking vascular phantoms in Aim 1, and rat models of PAD
in Aim 2. The ultimate goal of the two-year R21 phase is to achieve a clinical grade mPAI device with reliable
vascular imaging metrics.
In the R33 phase, to test the clinical performance of the mPAI, the following multicenter pilot clinical studies
on PAD patients will be conducted in 1) Penn State Hershey medical center, 2) Vikram Hospital in India through
collaborations with the IISc team, and 3) in Ghana in Year 5 with the help of Dr. Colette Pameijer of Penn State
who conducts medical camps in Ghana every year through Penn State Global Health Program. Clinical studies
in R33 phase will be undertaken only if well-defined milestones are achieved in the R21 phase.
The overall goal of these studies is to carefully validate the clinical potential of emerging label-free
photoacoustic imaging technology to screen for vascular diseases, in a portable form, in resource poor settings
of the world.

Public health relevance
Project Narrative Vascular diseases are becoming epidemic with increase in aging population, obesity and type II diabetes. They affect humans of all age groups, including neonates. This proposal aims to develop and validate the first ever portable photoacoustic imager for diagnosing and monitoring vascular diseases in resource poor settings.